The Role of Intersectional Stigma and Social Anxiety in Substance Use and HIV Risk for Young Men of Color

PROJECT SUMMARY/ABSTRACT
Young sexual minority men (YSMM) aged 16-29 are at increased risk of acquiring HIV. YSMM who find
themselves in the period of adolescence and emerging adulthood face many physical and psychosocial
changes, including potential experiences of discrimination and prejudice due to their sexual minority identity
(i.e., minority stress). These experiences in turn may increase their susceptibility to engage in negative health
behaviors that place them at higher risk of acquiring HIV, such as substance use and condomless anal sex
(CAS). Emerging adulthood has also been found to be the period with the highest reported substance use, and
sexual minorities engage in more substance use compared to their heterosexual peers. Furthermore, higher
levels of substance use have been associated with higher engagement in CAS. However, while minority stress
has been used to understand these disparities, this alone does not explain why Black and Latino YSMM
experience an even higher risk of acquiring HIV compared to their White peers despite reporting overall less
risky health behaviors. A growing body of literature has begun to highlight intersectional stigma–a form of
stigma caused by one's interlocking marginalized identities–as a cause for this disparity. Additionally, research
on the underlying mechanisms between intersectional stigma and negative health risk behaviors are
understudied, but empirical work suggests social anxiety may play a role in this association. Sexual minorities
have been found to meet criteria for social anxiety disorder at higher rates than their heterosexual
counterparts, and minority stress has been hypothesized to be a driver of this given the hypervigilance and
expectations of rejection these experiences instill on sexual minorities. However, both the prevalence and
effects of social anxiety on the negative health behaviors that increase risk of acquiring HIV among Black and
Latino YSMM are understudied. Therefore, building off minority stress theory and intersectionality framework,
the primary goal of this Diversity-F31 study is to examine the association between intersectional stigma,
substance use, and CAS among Black and Latino YSMM, and assess for the role of social anxiety
symptomology in these associations. The study focuses on two aims: (1) examine if Black and Latino YSMM
who experience clinically elevated levels of social anxiety have stronger associations between experiences of
intersectional stigma, substance use, and CAS; and (2) examine the mechanistic role of daily socially anxious
symptomology at the within-person level in the association between daily experiences of intersectional stigma,
substance use, and CAS. The proposed project will be embedded into a larger daily diary study of
intersectional stigma among YSMM (R21-MH121311, PI: Rendina). The proposed project will add daily
measures of social anxiety. The research and training plans proposed for this project are also designed to
foster my development as a health psychologist and clinical scientist with a solid foundation in intersectional
stigma, substance use, HIV treatment and prevention, and social anxiety among Black and Latino YSMM.

Public health relevance
Project Narrative/Public Health Relevance This study was designed to investigate the association between experiences of intersectional stigma, social anxiety, substance use, and HIV risk (i.e., condomless anal sex) for Black and Latino young sexual minority men (YSMM). Utilizing an intersectional framework, this study will help clarify and enhance understanding of how experiences of stigma unique to an individual's interlocking marginalized identities can heighten the risk of engaging in transmission risk behaviors through its associations with social anxiety symptomology. The proposed study will look at whether social anxiety explains the role of intersectional stigma in health risk behaviors. A greater understanding of the role of both intersectional stigma and social anxiety in influencing risk behaviors among is crucial in order to develop culturally-tailored HIV prevention interventions among Black and Latino YSMM.